Future Research Directions on Lipid and Lipoprotein Metabolism and Alzheimer's Disease (AD) and AD-related Dementias

Logistical support services for event titled Future Research Directions on Lipid and Lipoprotein Metabolism and Alzheimer's Disease (AD) and AD-related Dementias.